Annual Conference on Health IT & Analytics 2021-2023

Project Summary
Driven by the continuing digitization of medical information, innovations in information technology and
applications of artificial intelligence, and policy developments, the healthcare landscape is changing dramatically.
New opportunities and challenges emerge daily regarding the design, implementation, management, use, and
evaluation of Health IT and Analytics (HITA), and in particular, artificial intelligence (AI) methods, to support the
mission of fostering a learning healthcare system, which promotes evidence-based improvements in healthcare
quality, patient safety, whole-person care, affordability and access. These digital healthcare innovations
represent significant and unprecedented translational research opportunities, which have the potential to
influence practitioners, policymakers and consumers. As the use of AI in healthcare grows it is essential to solve
issues surrounding the ethical, unbiased, and appropriate implementation and use of AI towards clinical, patient
empowerment, and administrative knowledge needs. CHITA’s primary aim in the 2021-2023 grant period is to
improve the use of evidence-based practices regarding effective and non-biased implementation of digital
healthcare and AI tools. We will synthesize and disseminate implementation research and lessons learned of
digital healthcare tools with an emphasis on the appropriate, ethical use of AI towards healthcare decision-
making, quality whole-person care, and value-based transformation efforts. CHITA will provide a forum for
disseminating and catalyzing cross-disciplinary cutting-edge research that links transdisciplinary research
communities with policy and practitioners to curate and present user-focused research, exchange ideas, and
learn about current policy issues. CHITA also aims to empower the next generation of health IT and analytics
researchers through a variety of programming that empowers dozens of students and early career scholars every
year, including via a doctoral consortium, presentation opportunities, and engagement with senior researchers,
policymakers, patient advocates and practitioners. Entering its 12th installment, each year CHITA convenes over
120 participants representing researchers, policy professionals, patients and practitioners including scientists
from approximately 40 universities who present their latest findings. 2021-2023 conference sessions will be
tailored to critical AHRQ topics of interest and AHRQ digital health grantees will be encouraged to showcase
their work. CHITA is positioned in a unique niche that is not addressed in the same depth by any of the larger
health services research conferences. CHITA’s format supports intimate, rich, and detailed interaction and
discussion that is often infeasible in large conferences. CHITA enables the development of human capital in a
constructive setting. CHITA is exceptionally positioned to continue contributing to the nation’s journey towards a
more effective and value-based healthcare system, which uses digital healthcare and AI productively and
equitably.

Public health relevance
Project Narrative The Conference on Health IT and Analytics (CHITA) is an annual research summit, including a doctoral consortium that each year convenes leading scholars and students from more than 40 research institutes, with prominent policy and practitioner speakers and attendees. The conference provides a vibrant setting to foster digital healthcare and AI implementation lessons for dissemination and advance translational research regarding the design, implementation, use, management, and impact of health IT and analytics, with a focus on the ethical and equitable use of artificial intelligence (AI). The conference plays a critical role in facilitating interactions between scholars, government, and industry, fosters a multidisciplinary health IT and analytics research community, nurtures the next generation of health IT and analytics researchers, and supports the national agenda for a learning health system, which promotes evidence-based improvements in healthcare quality, patient safety, whole-person care, affordability and access.